Finding Sleeping Beauty: T Cell Biosensors for Dormant Cancer Detection

PROJECT SUMMARY
Some types of cancers, as exemplified by estrogen receptor positive breast cancer, can recur as metastatic
disease many years or even decades following a dormancy period where the patient displays no clinical
symptoms. Late recurrence is thought to arise from disseminated tumor cells (DTCs) that were not killed by initial
treatment and that lie dormant at metastatic sites such as the bone marrow until they reawaken. Strikingly, meta-
analysis of over 60,000 early-stage ER-positive breast cancer patients treated with endocrine therapy revealed
that the relative risk of recurrence progressively increases over a period of at least 20 years, indicating that
patients in complete remission with no evidence of disease could harbor dormant cancer and remain at risk of
metastatic relapse for the remainder of their life. Currently, there is no widely used method to monitor the dormant
state nor its reawakening. The arrival of cancer immunotherapy has revealed exciting possibilities using
engineered T cells as living medicines. T cells designed with tumor-targeting receptors and sophisticated genetic
circuits have led to striking treatment responses in patients with certain types of cancers that were previously
untreatable. This moment is an opportunity to not only build a future where T cells are engineered as therapies,
but also as living sensors that can detect cancer with sensitivities and specificities beyond what is currently
possible. The activation and growth of dormant tumor cells into micro-metastases require the hallmark
expression of proteases during key steps such as angiogenesis. To exploit protease dysregulation, this project
will develop engineered receptors that sense proteolysis to detect reawakening. These contain an extracellular
single chain antibody that is blocked by a peptide mimotope such that they can bind to their cognate antigens
only after the blocking peptide is removed by proteolysis, restricting T cell activation to the specific condition
where the cognate protease and tumor antigen are both present. Following activation, T cell sensors amplify the
release of synthetic biomarkers (blood, urine and imaging) for detection. Genetically encoded libraries (>10^4)
of protease-activatable receptors will allow in vivo screening of 1000s of candidate T cell sensors to positively
and negatively select for constructs that can report on awakening in different microenvironments such as the
bone marrow and lungs. The adoptive transfer of T cell sensors with memory phenotype could lead to life-long
T cell sensors that continuously monitor for future disease. These technological breakthroughs will have huge
implications in understanding how and when dormant cells reawaken and guide therapeutic interventions at the
earliest stages of reactivation.

Public health relevance
PROJECT NARRATIVE Some types of cancers, as exemplified by estrogen receptor positive breast cancer, can recur as metastatic disease many years or even decades following a dormancy period where the patient displays no clinical symptoms. This proposal seeks to engineer T cells as ultrasensitive biosensors to detect dormant cancer and when they reawaken.